Macromolecular Substrate Recognition in Blood Coagulation

The specifipcroteolytiactivatiosntepsof bloodcoagulationarccatalyzedby scrineprotcinasetshatarehomologous toeach otherand tothearchetypalserincprotcinascosf digestionI.n many cases,explanationfsorthemolecularbasis of thedistinctimvaecromolccularsubstratscpecificitoyf thecoagulationreactionrsemain incomplete.Evidence suggeststhatprothrombinactivatiobny theprothrombinascornplcxr,esultfsrom interactionastan extended macromolccularrecognitiosnite(Exositeso)n theenzyme followedby activcsiteinteractionpsriorto cleavageand productrcleascW.c willuseprothrombinactivatiocnatalyz_ by theprothrombinasecomplex as a paradigm for specifimcacromolccularsubstratrcecognitioannd cleavageby coagulationcomplexes to investigatehebasisforits substratscpecificiatnyd functionU.sing fluorescenstubstratacnalogs,bindingand stoppedflow kineticmeasurements by resonanceenergytransfewrillbc used toinvestigatcexositcbindingand providea completekineticand thermodynamic descriptionf thestcpwiscinteractiontshatleadto substratrcecognitionand cleavage.Wc willtesthe hypothesisthatextendedsurfacesinfactorXa playa major roleinexositc-dcpcndcnstubstratreecognitionby prothrombinascT.hese structurafleatureswillbc exploredwithexositcprobesthatbindXa and selectiveliynhibit proteinsubstratbcinding.Using thebindingfootprinotf cxositc-directperdobesas a guidelinew,c willprovidefull biochemicalprooffortheseideasby preparingrecombinantXa derivativewsith a selectivdefectin cxositc-depcndcnt substratrcecognitiownithinprothrombinascW.c willinvestigatehehypothesisthatheorderedaccessibiliotfythetwo bonds inprothrombinby prothrombinasearisesfrom thecombined constraininegffectosf cxositctetherinagnd membrane bindingby thesubstratcT.hese bindinginteractionasrcproposedtoboth facilitatned constraibnond presentatioand thespecifiactionofprothrombinascon prothrombin.Inthelastseriesof studiesw,c willinvestigate thehypothesesthatheinitiaelxositetetherinignteractiowniththesubstratoevercomes both cnthalpiacnd cntropic limitationosf activesitedockinginteractiontsherebyieldingvastimprovements incatalytircateand leadingtothe orderedcleavageofprothrombin.We believethatheapproachescontainedinthisproposalwillprovideunanticipated insightsintothefunctionof thecoagulationenzymes and a new perspectivoen themechanism of actionof prothrombinascon itsbiologicaslubstrateT.he delineationf thedeterminantosf macromolecularsubstratscpecificity willlikelysuggestnovelapproachesfortherapeutitcargetinogf thesereactionisnthromboticand vasculardisease states.